Development of drug delivery system that modulates adipose tissue function.

PROJECT SUMMARY/ABSTRACT
Obesity, affecting over 40% of U.S. adults, is a major health concern that contributes to the development of
metabolic disorders such as type 2 diabetes and insulin resistance. Current FDA-approved hunger suppressant
drugs can induce weight loss but do not directly impact adipose tissue, leading to quick weight regain once
treatment is stopped. White adipose tissue (WAT), which stores excess fat, plays a central role in obesity, while
brown adipose tissue (BAT) helps burn fat through fat oxidation, converting fatty acids into energy and increasing
thermogenesis. This project aims to create a drug delivery system that is retained in the adipose tissue and
promotes fat browning—the conversion of WAT to a more metabolically active state similar to BAT—to enhance
systemic metabolism. The overarching goal is to develop a locally injected adipose tissue nano-reservoir for
continuous delivery of forskolin, a cyclic AMP activator molecule known to stimulate fat thermogenesis in adipose
tissue. The project comprises three specific aims: Aim 1 focuses on establishing a correlation between the
physicochemical properties of engineered hybrid lipid-coated mesoporous silica nanoparticles (LCMSN) and the
cell uptake in the adipose tissue as well as the in vivo distribution of LCMSN and forskolin, assessing how shell
configurations impact cell retention, forskolin release and efficacy. Aim 2 aims to identify the optimal properties
and dosing strategies for the LCMSN to effectively induce thermogenesis in WAT, evaluating its impact on
systemic metabolism, energy expenditure, and weight management in mice on a high-sucrose high-fat diet. Aim
3 will determine the efficacy of this nanomedicine in promoting weight loss in a diet-induced obesity model,
correlating treatment outcomes with changes in food intake, body composition, and metabolic markers. Through
preclinical studies, this project seeks to assess the impact of optimized forskolin delivery on weight management
and metabolic health, ultimately creating a novel targeted tool for long-term obesity management and improved
patient care.

Public health relevance
PROJECT NARRATIVE Obesity affects over 40% of U.S. adults, driving significant healthcare costs and contributing to widespread metabolic disorders. This project seeks to develop an innovative nanomedicine that complements or amplifies the effects of existing FDA-approved obesity treatments by stimulating thermogenesis in white adipose tissue and improving systemic metabolism. By engineering a nano-reservoir for the controlled delivery of forskolin, we aim to prevent weight gain and enhance metabolic health through sustained thermogenic activity and increased fat oxidation.